University of Washington Developmental AIDS Research Center for Mental Health (UW ARCH)

Project Summary/Abstract
Despite availability of HIV pre-exposure prophylaxis (PrEP) for over a decade, many persons who could benefit
from PrEP have not yet accessed PrEP services. Implementation of pharmacy-based PrEP is a promising
strategy that presents opportunity to overcome barriers related to clinic distance and stigma and to increase
PrEP access, uptake, persistence, and adherence among individuals who would benefit most.
Despite the fact that project team member and pharmacist Dr. Elyse Tung started the first pharmacy-based
PrEP clinic in Seattle nearly ten years ago, PrEP still is not widely available through pharmacies without a
prescription from a licensed doctor or other clinician. As of 2023, not all states allow pharmacists to prescribe
and dispense PrEP without a doctor’s prescription, and many insurance companies erect barriers to providing
compensation to pharmacists for this role. Work is needed to develop and refine the training and educational
support specifically required by pharmacists to expand their scope of practice and to advocate for supportive
policies.
This administrative supplement application to the Ending the HIV Epidemic (EHE) initiative proposes two
specific aims. Aim 1 will establish an online virtual community of practice (VCoP) for pharmacists and
pharmacy staff to increase their knowledge, capabilities, and comfort in prescribing PrEP. The second aim will
outline a comprehensive PrEP curriculum for pharmacists, technicians, and students. Ultimately, the goal of
this supplement is to support sustainable pharmacy-based programs that will increase the number of people
starting and continuing PrEP in EHE jurisdictions across the United States.
This project addresses the Prevent pillar of the EHE plan with a secondary impact on the Diagnose pillar. This
project also addresses the NIH HIV/AIDS Research Priorities (NOT-OD-20-018) to reduce HIV incidence by
testing new prevention strategies and training the HIV workforce. It is in synergy with the local EHE plan (see
Letter of Support from Ms. Hutcheson, EHE Program Manager), the Washington State Department of Health
(see Letter of Support), and the National HIV/AIDS Strategy. The national strategy specifically calls out to
leverage pharmacists’ knowledge and accessibility in nearly every urban and rural community as part of a
comprehensive HIV prevention and care strategy. Ultimately our goal is to provide more PrEP options and
expand access points for PrEP care in locations and to populations disproportionately impacted by HIV
infection.in order to end the HIV epidemic.

Public health relevance
Project narrative The National HIV/AIDS Strategy explicitly calls out the potential for pharmacists to assist in ending the HIV epidemic. This project would work to develop a training curriculum for pharmacists and build an online community of pharmacists and pharmacy staff that would provide education and support. Ultimately, the goal of this supplement is to support sustainable pharmacy-based PrEP programs that will increase the number of people starting and continuing PrEP in EHE jurisdictions across the United States.